Core C - Genomics, CRISPR, and Gene Perturbation Core

The overall goal of this IR-PPG is to use cellular and transcriptomic guided approaches to define the causal
mechanisms by which PD1 and LAG3 control diverse types of T cells in the context of autoimmunity, cancer,
and chronic infection. A major approach to be used throughout this Program is single cell sequencing, including
single cell RNA sequencing (scRNA-seq) and/or scATAC-seq linked to downstream CRISPR screening to define
causal mechanisms. Thus, the purpose of the Genomics, CRISPR, and Gene Perturbation Core (Core C) is to
provide essential and centralized integrated analysis of key datasets and design of common CRISPR screening
libraries for use across all three Projects in this Program. In addition, this Core will provide advanced
computational analysis and provide a platform for a retroviral or lentiviral (RV/LV)-enforced expression and
knockdown to use to directly test in vivo individual genes and pathways identified from CRISPR screening. Thus,
Core C will provide integrated bioinformatic and computational analytical platforms and data integration services
coupled to downstream RV/LV-enforced expression and knockdown as well as in vivo CRISPR/Cas9-focused
genetic screening. The Aims are:
AIM 1: To provide advanced computational support and identify mechanistic targets of PD1 and/or LAG3
for CRISPR-based screening through cross-Project data integration, advanced computational analyses,
and sgRNA library design. Core C will provide five services: [i] support data ingest and analysis for cross-
Project analysis and CRISPR library development; [ii] ingest, quality control, and normalize external datasets for
integrated analysis with IR-PPG datasets; [iii] perform integrated analysis to identify common and disease-
specific biology linked to PD1/LAG3; [iv] assist the Projects in implementing novel analytical pipelines and data
analysis tools; and [v] develop focused CRISPR libraries.
AIM 2: To enable in vivo CRISPR/Cas9 screening and provide a retrovirus/lentivirus-enforced expression
and knockdown platform for in vivo testing of genes of interest (GOI) regulated by PD1 and LAG3. Several
robust in vivo CRISPR/Cas9 screening platforms for genetic perturbation in T cells in mouse models of disease
have been established in the IR-PPG to test causality of genes identified through transcriptional analysis. Core
C also has developed a robust retrovirus/lentivirus gene manipulation platform to advance from causal
implications to mechanistic understanding of GOI. Core C will provide tools to test causality and interrogate
mechanisms through two services: [i] provide common CRISPR libraries and facilitate CRISPR library
construction in retrovirus/lentivirus for in vivo screens; and [ii] provide retrovirus/lentivirus-based tools to test
mechanisms of GOI implicated downstream of PD1 and/or LAG3.
IR-PPG Interactions: Core C will analyze samples and integrate data for the three Projects. Core C will interact
heavily with Cores A, B, and D to identify gene targets for novel mouse strains and antibody development.

Public health relevance
Project Narrative Autoimmunity, cancer and chronic infections are significant causes of morbidity and mortality. T cells are central to these diseases and their activities are regulated by the cell surface inhibitory receptors PD1 and LAG3. This Core will provide services to use genomic sequencing, CRISPR and computational approaches to define the role of the inhibitory receptors PD1 and LAG3 in autoimmunity, cancer and chronic infections.